Molecular and cellular underpinnings of limbic-predominant age-related TDP-43 encephalopathy neuropathological change (LATE-NC)

PROJECT SUMMARY/ABSTRACT
LATE-NC (limbic-predominant age-related transactive response DNA-binding protein of 43 kDa [TDP-43]
encephalopathy neuropathological change), a recently recognized form of TDP-43 proteinopathy, is the third
most impactful cause of dementia following Alzheimer’s disease neuropathologic change (ADNC) and
cerebrovascular disease, accounting for 15-20% of all dementia cases in older adults. Genetic association
studies by our group and others revealed unique, LATE-NC-specific risk loci as well as those shared with other
common dementia-causing proteinopathies. A transcriptomic study from our group implicated endo-lysosomal
dysregulation as a crucial pathophysiologic process underlying LATE-NC. However, molecular and cellular
underpinnings of LATE-NC remain largely unknown: we do not even have the knowledge to develop in vitro/in
vivo disease models or nominate target pathways, and as a result, we cannot diagnose, treat, or prevent
LATE-NC in living persons yet. Defining molecular and cellular changes underlying LATE-NC is a prerequisite
to developing translatable in vitro/in vivo disease models and identifying biomarker/therapeutic targets. This
critical knowledge gap has been acknowledged by the NIH AD-Related Dementias (ADRD) Summit in 2022,
which made a high-priority recommendation to investigate molecular changes associated with LATE-NC.
Therefore, this proposal aims to define the transcriptomic, proteomic, and cellular underpinnings of LATE-NC
in the human amygdala, the brain region where LATE-NC is thought to originate. Our central hypothesis is that,
in the amygdala, endo-lysosomal dysregulation, altered RNA metabolism, glial dysfunction, and neuronal loss
underlie LATE-NC pathophysiology. To test the central hypothesis, we propose to generate and analyze
transcriptomic, proteomic, and single-nucleus multiome (transcriptome and chromatin accessibility) data from
the post-mortem amygdala samples from the extensively characterized Religious Orders Study and Rush
Memory and Aging Project participants (n=480). We will pursue the following three specific aims: First, we will
determine the transcriptomic underpinnings of LATE-NC. Second, we will identify the proteomic signature of
LATE-NC. Third, we will define the single-cell landscape of LATE-NC. We will use statistical modeling
approaches to infer causal relationships. We will consider sex-specific effects and the confounding effect of
comorbid ADNC pathology throughout the study. The expected outcomes of this project will nominate protein
biomarker targets and define plausible upstream and downstream events of LATE-NC. These results will guide
our future studies to develop in vitro and possibly in vivo LATE-NC models and, eventually, targeted
therapeutics. The large-scale amygdala multi-omic data will be broadly shared with the scientific community to
support numerous ADRD research projects, ensuring a significant lasting impact in neurodegeneration
research far beyond this proposal. Therefore, this project has the potential to fundamentally improve our ability
to diagnose, treat, and ultimately prevent dementia, including LATE.

Public health relevance
PROJECT NARRATIVE LATE-NC (limbic-predominant age-related transactive response DNA-binding protein of 43 kDa [TDP-43] encephalopathy neuropathological change) is the third most impactful cause of dementia, but we cannot yet diagnose, treat, or prevent LATE-NC in living persons. This project seeks to define molecular and cellular signatures of LATE-NC by detailed profiling of hundreds of human brain samples, and to generate a comprehensive roadmap for model system development, diagnostic biomarker discovery, and therapeutic target identification. As LATE-NC is a common and pernicious brain disease that primarily affects the oldest old, the most rapidly growing segment of the population in the United States, this project has the potential to have an enormous public health impact.